Targeting Mitochondrial Cyclophilin D in Vascular Oxidative Stress and Hypertension

Project Summary
Hypertension is a major health problem in Western Societies and a risk factor for stroke, myocardial infarction, and
heart failure and therapies specifically targeted at mitochondria represent promising strategies to reduce target-
organ-damage. Mitochondrial permeability transition pore (mPTP) plays a key role in mitochondrial dysfunction
and target-organ-damage in hypertension. We discovered that depletion or inhibition of Cyclophilin D (CypD), a
regulatory subunit of mPTP opening, improves vascular function and attenuates hypertension. Meanwhile, the
tissue specific role of CypD and molecular mechanisms of CypD activation are not known. In the proposed studies,
we will take this work forward by defining the role of vascular CypD and therapeutic potential to target CypD in
endothelial dysfunction and hypertension. Our studies in human subjects with essential hypertension showed CypD
hyperacetylation and implicate CypD activation by K166 acetylation due to imbalance between GCN5L1 acetyltransfe-
rase and reduced Sirt3 deacetylase activity. Sirt3 is inactivated by highly reactive mitochondrial lipid dicarbonyls,
isolevuglandins (isoLG), while isoLG scavenging prevents CypD acetylation and reduces hypertension. We propose
targeting mitochondrial CypD to inhibit oxidative stress, improve vascular functions and reduce hypertension. The
overall objective of this proposal is to define specific mechanisms of CypD mediated vascular oxidative stress
and test the therapeutic potential of targeting CypD in hypertension. We will pursue the following aims:
AIM 1. To test the hypothesis that cell specific CypD depletion in endothelial and smooth muscle reduces vascular
oxidative stress, protects vascular relaxation and attenuates hypertension. In this aim we will examine the
protective role of CypD depletion in inducible endothelial specific CypD knockout (EcCypDKO) and smooth
muscle specific CypD knockout (SmcCypDKO) mice using AngII and DOCA-salt models of hypertension.
AIM 2. To test the hypothesis that CypD-K166 acetylation contributes to vascular dysfunction and hypertension. We
will define the pathophysiological significance of CypD-K166 acetylation using new deacetylation mimic
CypD-K166R mutant mice, new endothelial specific GCN5L1 knockout mice (EcGCN5L1KO), and endothelial
specific Sirt3 knockout mice (EcSirt3KO). All mice are available in our lab.
AIM 3. To test the hypothesis that CypD inhibition and blocking CypD hyperacetylation after onset hypertension
improve vascular function. We will test if CypD blockers improve vascular function and reduce blood
pressure in hypertensive mice. We will study CypD acetylation in resistance arteries isolated from human
subjects with essential hypertension and test if CypD blockers improve human endothelial function.
We are in an ideal position to perform these interdisciplinary studies. We developed new CypD transgenic mouse
models and mitochondria-targeted treatments. We have access to human vascular tissue and unique expertise
in oxidative stress, human vascular studies and hypertension. Our data strongly support this novel pathway in
vascular dysfunction, and this work has the potential to make a major impact on the development of new treatments.

Public health relevance
Project Narrative Clinical data show that one third of adult population has hypertension; however, despite treatment with multiple drugs, third of hypertensive patients remain hypertensive which can be potentially corrected with new classes of antihypertensive agents. We have discovered a novel mechanism mitochondrial dysfunction mediated by Cyclophilin D hyperacetylation in human subjects with essential hypertension and developed new mitochondria- targeted drugs to reduce blood pressure and mitigate the end-organ-damage in hypertension. In the proposed studies, we will take this work forward by defining the cell-specific role of vascular cyclophilin D and establish the therapeutic potential of targeting Cyclophilin D in vascular dysfunction and hypertension using novel animal models and vascular tissue from subjects with essential hypertension.